Magnetogenetic control of vulnerable brain cell types in Alzheimer's disease

Abstract
Alzheimer’s disease (AD) is a progressive disease and is the most prevalent neurodegenerative disease
underlying dementia in the elderly. AD is known to progress following a temporal and spatial pattern where
specific brain regions are affected at different stages of the disease. While both β-amyloid plaques and tau
neurofibril tangles are hallmarks of AD, tau pathology shows a stronger correlation with cognitive decline. Tau is
predominantly produced by neurons, yet different brain regions and neuron types exhibit varying vulnerability to
tau pathology. AD-vulnerable neurons exhibit hyperexcitability linked to tau accumulation and secretion,
observable even before AD onset. Secreted tau spreads between neurons and astrocytes, promoting tau
pathology. Early AD astrocytes show abnormal calcium signaling, potentially impairing tau clearance. Therefore,
to better understand the molecular mechanisms and explore new AD therapeutics, it is essential to regulate the
activity of specific AD-vulnerable neurons and their associated astrocytes. We propose to develop
magnetogenetic techniques with better efficiency and cell specificity enabled by enhancer AAV to manipulate
subtypes of brain cells implicated in AD onset. Using these tools, we will test cell-type specific hypotheses
underlying the accumulation, spread, and clearance of tau proteins across species. To control the activity of
these cells, we will employ FeRIC (Ferritin iron Redistribution to Ion Channels), a magnetogenetic tool that we
have pioneered. FeRIC can wirelessly and non-invasively modulate cell activity and achieve cell-type specificity
and deep brain access. Enhancer AAV vectors will be developed to drive cell type specific expression of FeRIC.
By combining brain cell type-specific enhancer AAV vectors and FeRIC, we will develop cell-type specific non-
invasive techniques to manipulate AD-vulnerable neurons and astrocytes and test their roles in AD onset and
propagation with cellular, circuit, and temporal precision, in rodent models both in vitro and in vivo, and
exploratorily in ex vivo human and non-human primate brain tissues. A successful outcome will elucidate the
mechanistic actions of tau pathology in early AD onset through non-invasive, cell-type-specific manipulation of
AD-vulnerable neurons and astrocytes, potentially reversing the disease's progression.

Public health relevance
Narrative Alzheimer's disease (AD) is a progressive disease and is the most prevalent neurodegenerative disease underlying dementia in the elderly. If successful, the project will not only provide insights on the cell-type specific fundamental mechanisms of tau pathology in AD but also provide a potential therapeutic pathway.